ANTIBODY STRUCTURE &GENETIC ENGINEERING: COMPUTATIONAL MODEL, ANTIGEN BINDING

We are studying the structures of three antibodies the F ab of humanized OKT4A, and two metal-binding mutants of the single-chain F v of the catalytic antibody 43C9. Computational models of the antigen binding regions of all three antibodies have been constructed and will be compared to the crystal structures to ascertain the predictive power of the modeling techniques. High resolution structures will be needed to clearly define the mechanisms and properties of antigen binding by these proteins.